UNM FIRST: Faculty Development Core

FACULTY DEVELOPMENT CORE SUMMARY/ABSTRACT
Recruitment and retention of a diverse biomedical faculty workforce is necessary for the National Institutes
of Health mission of discovery and innovation toward improving human health. However, the success of this
mission requires institutions to change their culture so that faculty who belong to historically disadvantaged and
underrepresented racial and ethnic groups do not face challenges such as marginalization, lack of appropriate
mentoring, lack of visibility and recognition of scholarly achievements, and tokenism. Our long-term goal is to
transform institutional culture at The University of New Mexico (UNM) to systemically achieve diversity of the
biomedical workforce and sustained inclusive excellence. Recent efforts led by the National Science
Foundation UNM ADVANCE program have begun to support cultural change towards inclusive excellence at
UNM. Yet, transformation requires hiring, promoting, and retaining diverse early career faculty, a recalcitrant
challenge among NIH-funded institutions across the U.S. The central hypothesis of this proposal is that the
UNM FIRST program will successfully hire, promote, and retain a cohort of early career faculty who will
accelerate significant discoveries in the interdisciplinary fields of neuroscience and data science. The specific
aims of the UNM FIRST Faculty Development Core are: to establish a program that reduces isolation and
increases community building for the UNM FIRST faculty hires (AIM #1); to develop personalized faculty
career and research development plans for each of the UNM FIRST faculty hires (AIM #2); to develop a
retention toolkit for the UNM FIRST faculty cohort (AIM #3). The proposed mentoring plan, networking
activities, professional development resources and retention toolkit will be institutionalized thanks to the
Institutional Innovation Implementation Board (I3 Board), that includes key administrators and stakeholders at
UNM who have committed to UNM Institutional support of the UNM FIRST program. The significance of the
proposed work is that careful implementation of the Faculty Development Core activities will not only increase
the likelihood of the UNM FIRST cohort to secure extramural R01 or equivalent NIH funding and achieve
professional legitimacy in their fields but will also impact all future diverse faculty hires at UNM. Importantly,
supporting faculty development of a diverse workforce in a majority-minority state and Hispanic Serving
Institution will subsequently provide a pipeline for increasing the diversity of the biomedical workforce by
offering diverse faculty representation as role models for female and historically underrepresented trainees.
UNM will be the home of diverse faculty who will attain professional legitimacy while building careers they love
in a welcoming scientific community where they belong, feel valued, and contribute to ongoing institutional
efforts to change the culture at UNM to promote inclusive excellence via systemic changes.